BIOMIMETIC METAL COMPLEXES OF MACROCYCLIC LIGANDS

Research carried out by this group on totally synthetic macrocyclic complexes has led to models which mimic important features of the active site of heme-containing monooxygenase enzymes exemplified by the cytochrome P450 family. These models have been shown to bind both organic substrates, through hydrophobic interactions, and the dioxygen molecule. This produces a ternary complex like that implicated in the catalytic action of cytochrome P450. The unique features of this synthetic ternary complex are the subject of ongoing studies by a variety of synthetic and analytical techniques. Recent NMR studies in these laboratories show that a large number of aliphatic and aromatic guests can be accommodated, regiospecifically, within the permanent cavity of the host, even in the presence of bound 0/2. The mutual interactions of these simultaneously bound species will be studied. Ultimate goals are directed toward the activation of bound 0/2 and the substrate specific, regiospecific, and stereospecific oxygenation of substrates. Reactive intermediates generated by oxygen atom donors are under study in attempts to contribute to the understanding of 0/2 activation. High valent oxometal complexes are of special interest in this regard. Experiments are being directed toward the study of the interconversion between coordinated peroxide in species such as FeIII (0/2/2-) and high valent oxometal species such as (Fe0)3+ because this process is essential to the activation process for the monooxygenase enzymes.